Core C - Resource Core

ABSTRACT
Critical to the evaluation of potential therapeutics (pharmacological, gene, or cell therapies) are sensitive and
repeatable physiological assessments of muscle function applied to mouse models of dystrophy. Therefore,
we are proposing to continue a research core that performs ex vivo, in situ, and whole animal assessments
of muscle integrity and function. This core will not only support the needs of the projects within the center, but
will also serve as a national resource for performing functional evaluation of potential therapies for the
muscular dystrophies. The Physiological Assessment Core resources are housed in the laboratory space
designated to Dr. Barton, the Core Director. Dr. Barton is a muscle physiologist with extensive experience
evaluating muscle function in mice. This includes all instrumentation for muscle physiological measurements,
specialized equipment for hindlimb suspension experiments, documented free wheel running, and treadmill
running, as well as interim storage of samples in both –80C and liquid nitrogen freezers. We propose to
collaborate with neighboring colleagues to assess whole animal respiratory function, which will complement
ex vivo assessment of the diaphragm.
We believe that this Core has provided a previously unmet need in the past 15 years of its existence, and will
continue to be a valuable resource that will enable the entire muscular dystrophy research community to
utilize these assays to assess the potential benefits of a large number of approaches to the treatment of
different forms of muscular dystrophy.